Sex-specific Impact of Prenatal Opioids on Brain Reward Signaling and Neonatal Feeding Regulation

Project Summary/Abstract:
Although Neonatal Abstinence Syndrome (NAS) is an urgent public health priority, the diagnosis and
management of NAS remains challenging. This is primarily due to the multifactorial nature of NAS and the
highly subjective measures to assess this condition. Males and females with NAS have distinct risk profiles, yet
within the current paradigm they are managed uniformly. The limited understanding of long-term outcomes
further compounds the problem and predisposes this population to a myriad of health issues. To address these
knowledge gaps, the current proposal expands upon the molecular and behavioral data from our K12-funded
pilot study to better understand the impact of prenatal opioid exposure. An early sign of withdrawal in opioid-
exposed neonates is difficulty feeding followed by hyperphagia, which often precedes severe NAS and the
need for pharmacotherapy. Using saliva collected immediately after birth, we showed higher expression of a
key reward gene (DRD2) in opioid-exposed males compared to females. The expression of DRD2 also
correlated with the caloric intake in opioid-exposed males who later developed severe NAS and required
pharmacotherapy. These transcriptomic-behavioral data indicate that prenatal opioid exposure dysregulates
brain reward signaling in a sex-specific manner, resulting in hyperphagia as a reward-seeking behavior that
offsets the acute loss of opioids. Furthermore, opioid-exposed neonates have heightened expression of
inflammatory genes (IL6, MCP1) that correlate with the expression of DRD2, particularly in females. Expanding
on these preliminary results, the current proposal will examine if prenatal opioids dysregulate brain reward
signaling and modulate pro-inflammatory pathways with increased sex-specific risks for hyperphagia and
associated long-term cardiometabolic disorders. Our overarching goal is to understand changes in sex-specific
reward and inflammatory gene expression in opioid-exposed neonates throughout the first year of life. The
hypothesis will be tested in two aims: 1) Identify sex-specific effects of prenatal opioids on reward signaling
and inflammation, 2) Evaluate effects of prenatal opioids on risk for subsequent cardiometabolic disorders. We
will collect serial saliva samples from 56 opioid-exposed and 56 sex- and age-matched non-exposed neonates
during the initial hospitalization and then in a subset of infants post hospital discharge up to 1 year of age to
evaluate the expression of reward and inflammation genes. Early cardiometabolic risk will be assessed using
serum lipid panels at 1 year of age, along with growth and nutritional data. Results will be analyzed by sex. The
impact of this proposed project lies in the potential to advance the field with a more comprehensive
understanding of the sex-specific impact of prenatal opioid exposure on the developing brain through non-
invasive molecular analyses, enabling personalized medicine and longitudinal health monitoring.

Public health relevance
Project Narrative: Neonatal abstinence syndrome (NAS) is a public health priority that remains difficult to diagnose and manage due to the lack of understanding of biological mechanisms underlying neonatal drug withdrawal. Utilizing a non-invasive salivary platform, the current proposal seeks to understand feeding difficulty and hyperphagia often seen in neonates with severe withdrawal and identify sex-specific expression of reward and inflammatory genes that may predispose these neonates to excessive weight gain and subsequent cardiometabolic disorders. The molecular approach and objective evidence from this study may identify at-risk neonates and enable personalized strategies that supplant subjective measures in the current treatment paradigm.